Bioengineered Prostate-on Chip: Mechanisms of Stromal Dysregulation in Prostate Cancer

ABSTRACT
It is well accepted that intrinsic action of the androgen receptor (AR) within the prostate epithelium drives prostate
cancer proliferation and survival. Less appreciated is the fact that AR is also expressed in the stroma surrounding
the epithelium. Stromal-expressed AR acts extrinsically to maintain the differentiated striated basal and luminal
epithelium of the normal gland. During prostate cancer development, AR expression in the stroma is lost. How
AR is lost from the stroma and how its loss promotes prostate cancer development is unknown. Our objectives
are to define the mechanism that leads to stromal-specific AR loss and determine how AR loss in the stroma, in
conjunction with epithelial oncogenesis, promotes prostate cancer development Based on our preliminary data,
we hypothesize that tumor-derived TNFα/TGFβ1 transcriptionally suppresses AR expression in the stroma,
causing loss of FGF10 and Wnt16 secretion, which are required to maintain the stratified epithelium through
induction of luminal cells and maintenance of basal cells, respectively. To test this, we developed the first human
Prostate-on-Chip model by culturing basal epithelial cells next to prostate stromal cells within a microfluidic
device. Within this model, we can fully recapitulate the stromal AR-dependent induction of luminal epithelial cell
differentiation. Furthermore, co-culturing normal stroma with tumor cells within this model leads to the induction
of CAF phenotypes and reduced stromal AR expression, mimicking the tumor/host interactions seen in vivo.
Models that recapitulate human glandular organization and its dysregulation during disease development are
critical for our mechanistic understanding of how stroma and oncogenic epithelial interactions drive tumor
development. We will test our hypothesis in three aims: 1) Determine the mechanism by which stromal AR
maintains prostate epithelial cell differentiation. Our working hypothesis is that stromal AR signaling induces
secretion of stromal FGF10 and Wnt16, which are required for induction of luminal epithelial cells and
maintenance of basal epithelial cells, respectively. 2) Determine the mechanism by which AR expression is lost
in the tumor stroma. Our working hypothesis is that tumor-secreted factors, TNFα and TGFβ1, acting through
NF-κB signaling, suppress transcription of the stromal AR gene independent of CAF conversion. 3) Determine
the functional consequence of tumor-induced stromal AR loss on prostate epithelial differentiation in a new de
novo in situ human prostate cancer model. Our working hypothesis is that tumor-induced stromal loss of AR-
dependent induction of Wnt16 and FGF10, via TNFα/TGFβ1, co-operates with epithelial oncogenes to accelerate
tumor development and induce loss of basal epithelial cells. The proposed studies will be the first to demonstrate
how TNFα/TGFβ-mediated suppression of stromal AR expression leads to the loss of Wnt16 and FGF10 to
promote prostate cancer development. These studies will also provide the framework for further development of
the first human Prostate-on-Chip model, which recapitulates human prostate biology, for basic and translation
cancer research.

Public health relevance
PROJECT NARRATIVE About one man in nine will be diagnosed with prostate cancer in their lifetime, about 80% of men who reach age 80 will have cancer cells in their prostate, but only one in 39 will die from it. Our ability to determine which patients will die is limited by our lack of understanding of how prostate cancer develops. The proposed studies will use new technologies to build better human models of prostate cancer to gain a better understanding of how prostate cancer develops.